Rabbit model for cystic fibrosis

DESCRIPTION (provided by applicant): Cystic fibrosis (CF) animal models have contributed significantly to understanding the mechanism of underlying disease. However, existing CF animal models have their limitations, either because the animal models fail to reproduce human phenotypes or because the animal models have very high maintenance costs and need specialized care. In addition, lacking good ΔF508CFTR animal model results in poor understanding the pathogenesis of the most common mutation in CF patients and halts CF drug discovery. Using CRISPR/Cas9 we have developed the first rabbit with the disruption of cystic fibrosis transmembrane conductance regulator (CFTR). Initial work on CFTR knockout rabbits (CFTR-/-) revealed lung pathology that is similar to that in human CF patients. In this application, we will test: Aim 1, generate rabbits carrying ΔF508 mutation (CFTRΔF508/ΔF508) in CFTR locus; Aim 2, generate gut-corrected CFTRΔF508/ΔF508 rabbits (TgCFTR-CFTRΔF508/ΔF508); and Aim 3, characterize CFTRΔF508/ΔF508 rabbits. The success of proposed work will provide an animal model for understanding the underlying molecular mechanisms, accelerating CF drug discovery and testing the efficacy of new drugs.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cystic fibrosis (CF) is the most common life-threatening monogenetic disease. The majority of human CF patients (>70%) carry the ΔF508 mutation in the CF transmembrane conductance regulator (CFTR) gene. We propose to develop ΔF508CFTR rabbits, which allow us to study CF pathology, and facilitate the development of therapeutic strategies for the disease.